Malaria Epidemiology across Rural and Urban Landscapes in Ethiopia

PROJECT 2
PROJECT SUMMARY
Malaria Epidemiology Across Rural and Urban Landscapes in Ethiopia
Although many rural areas of sub-Saharan Africa have achieved major reductions in malaria over the
past two decades, the malaria burden is increasing in rapidly growing urban regions of the continent.
Emergence of invasive Anopheles stephensi may further alter malaria transmission dynamics and
increase malaria risk in urban settings. This application responds to the World Health Organization’s
“Global framework for the response to malaria in urban areas,” a program launched in 2022 to address
the challenges of urban malaria control in the context of An. stephensi invasion in Africa. The central
objectives of this project are to advance knowledge of malaria epidemiology across the rural to
urban continuum in Ethiopia, where invasive An. stephensi presents a major threat, and to
examine the epidemiological impact of malaria vector control programs targeting areas at high
risk for malaria and An. stephensi distribution. The central hypothesis is that An. stephensi
invasion and rapid urbanization will modify malaria transmission dynamics and increase the
risk of malaria infection and clinical disease. Deeper understanding of these processes will
allow for the development of cost-effective malaria control strategies tailored to local urban
vector ecology and risk patterns. Three specific aims are proposed: 1) Determine the temporal
dynamics and spatial heterogeneity of malaria risk and underlying risk factors across the rural to urban
continuum in Ethiopia; 2) Assess the impact of urbanization and An. stephensi invasion on malaria
parasite within-host infection complexity and population-level genetic diversity; and 3) Evaluate the
epidemiological impact and cost-effectiveness of a larviciding program targeting areas of high malaria
risk in the rural to urban landscape. This project will reveal how An. stephensi invasion changes malaria
risk and influences susceptibility to clinical malaria and will provide critical information on the cost-
effectiveness of different microbial larviciding methods. Although this study will solely be conducted in
Ethiopia, we anticipate that our findings will have broad and timely implications for the assessment of
malaria risk and for malaria control in other African countries in the face of An. stephensi invasion.

Public health relevance
Public Health Relevance This project will significantly improve our understanding of the impact of Anopheles stephensi invasion on malaria risk across rural and urban landscapes, and identify more cost-effective malaria vector control methods in Ethiopia. This research will improve malaria control in Africa where the newly invaded An. stephensi species poses a major public health threat.